Engineered Gene Circuits for Basic Science and Biotechnology

Project Summary
We will continue to design, construct and characterize genetic circuits. We will use micro uidic tools
to grow and observe single cells and colonies in precisely controlled environmental conditions, and we will
test the engineered bacterial strains in tumor spheroids. We will characterize circuit-host interactions
and develop new design principles. The characterization of cellular behavior across multiple experimental
platforms will inform mathematical models that will be used to identify key design characteristics, which
will then be rigorously tested using previously established techniques. Two Postdocs, two Sta Research
Scientists, and a Graduate Student Researcher will work with Drs. Hasty and Tsimring on multiple aspects
of the project in an integrated manner. Our track record demonstrates our ability to train personnel in
a multi-disciplinary approach that has led to new tools for synthetic biology, along with an increased
understanding of gene and signaling networks generally.
Our recent characterization of bacterial circuits in animal models has served to highlight the need for
a better understanding of how engineered bacteria function in a tumor environment. Accordingly, our
Speci c Aims focus on the development of delivery circuits in small ecologies (Aim 1), the characterization
of engineered bacteria in tumor spheroids (Aim 2), and the interaction of circuits with their hosts (Aim 3).
Our rst aim is to develop small ecological delivery systems consisting of bacterial strains that can be found
in the tumor environment. One system will generate regular out-of-phase delivery sequences, while a second
will be designed for chaotic dynamics that could be useful for therapies that evade tumor adaptation. We
will develop computational models and experimentally quantify how the circuits behave in micro uidic
devices. While such mathematical models are generally e ective in predicting the population dynamics of
engineered bacteria when grown in isolation, the complex environment of a tumor does not represent a
simple extension of our existing understanding. The experimental cycle for animal models is too long and
costly for the development of an engineering-based approach to circuit design. Our second aim will be to
use a tumor spheroid platform for the development of mathematical modeling for engineered bacteria that
reside in tumors. We will use the ndings to identify essential modi cations to the computational modeling.
Finally, gene circuits are typically engineered with model equations that assume isolation from the host.
The third aim will combine integrative circuit-host modeling with a high-throughput micro uidic platform
to quantitatively characterize the bidirectional coupling between engineered gene circuits and their hosts.
We will explore the e ects of environmental constituents that are present in sold tumors and evaluate
the circuit-genome response to tumor spheroid lysate (from Aim 2). The goal of this aim is to deduce
fundamental principles that improve the design-build-test-re ne process for gene circuits.

Public health relevance
Project Narrative A natural therapeutic platform for synthetic biology arises from the propensity of some bacteria to prefer- entially grow in tumors. While simple bacterial expression systems may lead to important conceptual break- throughs, the power of synthetic biology arises from the vast potential for complex programming in a predictive manner. This project combines computational modeling, tumor spheroid technologies, and molecular biology to extend the engineering paradigm of synthetic biology to cancer therapeutics.